Yale Center for Metabolic Phenotyping in Live Models of Obesity and Diabetes

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The overarching goal of the Yale MMPC-Live is to provide extramural investigators access to the unique metabolic phenotyping services provided by the Yale MMPC-Live and empower them to harness the power of mouse genetics to its fullest potential to metabolically phenotype their mouse models of obesity and diabetes. The Yale MMPC-Live consists of three highly interactive Cores that have an established (>20 yr) track record of working together in close harmony: 1) The Yale MMPC-Live Administrative Core oversees the operation of the Yale MMPC-Live, facilitates research with the other MMPC Centers and the MMPC Coordinating Unit to standardize key methodologies, and coordinates the efficient workflow through the Yale MMPC-Live cores and access to the Yale MMPC-Live Animal Core and the Yale MMPC-Live Phenotyping Core, 2) The Yale MMPC-Live Animal Core provides a centralized facility for coordinating receiving, screening and monitoring mice from outside investigators and 3) The Yale MMPC-Live Phenotyping Core empowers Yale MMPC-Live clients with access to unique metabolic phenotyping services that provides them with the means to characterize the metabolic changes in their particular mouse models of complex metabolic disease using established state-of-the-art methodology. The Specific Aims of the Yale MMPC-Live are to: 1) serve the US academic research community to study diabetes and obesity in their mouse models by providing metabolic, physiologic, and behavioral phenotyping on live mice, as well as expert advice in mouse models, experiment design, data analysis, and data interpretation at similar cost whether inside or outside Yale without bias and, and collaborate to provide a wide array of tests and expert advice while avoiding unnecessary overlap, 2) Promote rigor and reproducibility in research by: a) developing and sharing validated protocols for phenotyping live mice; b) providing difficult experimental tests conducted by experts with a high degree of standardization and quality control, to PIs who would otherwise not be able to conduct or afford them; and c) sharing technologies and providing web-based tools for gold-standard approaches in experimental methods and data analysis, 3) Develop standardized data formats and storage guidelines for complex data, including metadata, for sharing with clients and the public as appropriate, and employ unique Research Resource identifiers (RRID), Digital Object Identifiers (DOI), and other best practices directed by DKNet.

Public health relevance
It is anticipated that the results provided by the Yale Mouse Metabolic Phenotyping Center-Live will provide investigators with new insights into their mouse models of obesity and diabetes which in turn will lead to new therapies to treat these conditions.